PROCESSING OF VIRAL PROTEINS FOR T CELL RECOGNITION

Class I molecules of the major histocompatibility complex (MHC) consist of a highly polymorphic heavy chain complexed to beta2 microglobulin (beta2m). Class I molecules are expressed on virtually all cell types. Their sole function is to bind antigens and present them to T cell-bearing CD8 molecules. CD8+ T cells play a critical role in eradicating intracellular pathogens and tumors. They can also contribute to immunopathology, being involved in organ rejection and autoimmune diseases. There has been rapid progress in understanding the physical nature of the antigen-class I complex and in how antigens are generated and become associated with class I molecules in cells. Peptides of 8 to 15 residues produced from a cytosolic pool of proteins by cytosolic proteases are translocated into the endoplasmic reticulum (ER) by a MHC-encoded transporter complex known as TAP. Once in the ER, peptides (possibly after further trimming by peptidases) bind to class I molecules associated with TAP and are transported to the cell surface. In the past year, we have continued our studies of the assembly and trafficking of MHC class I molecules and have made progress on two fronts: 1) we developed fluorescent derivatives of antigenic peptides and used these probes to make several novel findings about the intracellular trafficking of class I molecules and antigenic peptides, and 2) we have studied the intracellular trafficking of class I molecules using [3H]-labeled saccharides to label class I-associated N-linked oligosaccharides.